HuR’s role in pancreatic cancer metastasis

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC), the most common pancreatic cancer pathologic subtype, has a 5-
year survival rate of only 13%, largely due to its metastatic propensity. Most patients present with metastatic
disease, rendering them ineligible for curative intent surgery. Among those that undergo a successful resection,
78% will have metastatic recurrence within 2-years. Despite significant efforts to identify metastasis-specific
driver mutations, few targetable pathways have been identified, underscoring the need to explore alternative
mechanisms, such as post-transcriptional regulation. Human antigen R (HuR, ELAVL1) is an RNA-binding
protein implicated in post-transcriptional regulation of stress-adaptive networks. We propose HuR is essential
for PDAC cells to overcome challenges associated with the metastatic cascade. Under stress conditions, HuR
stabilizes and enhances translation of mRNAs required for cellular adaptation. Preliminary data from our lab
reveal that HuR knockout (KO) in PDAC cells via CRISPR-Cas9 reduces liver metastatic burden in our orthotopic
murine metastatic model, highlighting HuR activity as a potential therapeutic vulnerability in metastasis. My
central hypothesis is that HuR is a key regulator of PDAC metastasis by selectively stabilizing pro-metastasis
mRNA targets. In Aim 1, I will investigate the functional role of HuR in supporting PDAC metastasis. I
hypothesize that HuR is most critical for metastasis during the outgrowth phase in the secondary site, when
PDAC cells must adapt to unique secondary site microenvironments. To test this, I will rescue HuR activity at
distinct stages of metastasis in our HuR KO murine model and monitor metastatic burden. Additionally, I will
assess HuR expression levels and activity in matched primary and metastatic tumors from human PDAC patients
to determine whether metastatic lesions have a greater reliance on HuR. In Aim 2, I will identify HuR-bound
mRNAs that mediate metastatic adaptation. I hypothesize that HuR modulates distinct mRNA targets and
pathways depending on site-specific stress conditions. To test this, I will perform RNA immunoprecipitation
sequencing (RIP-seq) on primary, liver, and lung metastatic PDAC tumors to comprehensively map HuR mRNA
binding targets specific to metastasis biology. These targets will be prioritized using PDAC patient RNA-seq
datasets and clinical data from the Brenden-Colson Center for Pancreatic Care (BCCPC) at Oregon Health and
Science University (OHSU). I will validate identified HuR-bound mRNA PDAC metastatic drivers as bona fide
HuR targets through various molecular techniques, such as independent RIP-qPCR, western blot analysis, and
actinomycin D decay assays. Lastly, I will assess the functional relevance of top targets using target site blockers
(TSBs) to disrupt HuR–mRNA target interactions and measure the effects on metastasis. Importantly, integrating
preclinical and clinical data will enhance the translational impact of these findings. Completion of this proposal
will elucidate a novel mechanism by which PDAC cells utilize HuR to successfully metastasize, identifying
specific HuR-dependent pathways as potential therapeutic vulnerabilities in PDAC.

Public health relevance
PROJECT NARRATIVE Metastatic disease is a major cause of pancreatic cancer morbidity and mortality, yet the mechanisms underlying progression are not well defined. The proposed research, herein, will interrogate the functional role of an RNA binding protein, HuR (ELAVL1), in pancreatic cancer metastasis, by post-transcriptional modification of mRNAs important for cellular adaptation to stress. Completion of this training proposal's aims will elucidate a novel mechanism by which pancreatic cancer cells utilize HuR to successfully metastasize, identifying specific HuR- dependent pathways as potential therapeutic vulnerabilities in pancreatic ductal adenocarcinoma (PDAC).